Understanding longitudinal trajectories of environmental factors and depression among minoritized adolescents

PROJECT SUMMARY
The applicant, Ms. Mia Campbell, proposes to investigate the complex relationships between
caregiver experiences of racial discrimination, environmental characteristics, and adolescent
depression, addressing a critical need in public health. This dissertation project will ultimately prepare the
applicant for an independent research career focused on improving the prevention and treatment of depression
and mood disorders among adolescents.
Adolescent depression is a pressing public health concern in the United States with marked disparities by
gender and race. The significance of this research lies in the increasing prevalence of adolescent depression,
especially among racially minoritized groups, and its profound and long-lasting consequences on individuals'
lives. Utilizing a unique dataset from the Environmental Influences on Child Health Outcome (ECHO) Program,
we will apply innovative methodologies to unravel these intricate connections. In Aim 1, we will identify latent
classes of caregivers based on their experiences of everyday racial discrimination and explore their
associations with adolescent depression. This study extends the existing body of research by incorporating
caregiver discrimination experiences as a crucial factor in understanding adolescent depression.
Aims 2 and 3 delve into the moderation effects of psychosocial and environmental factors on the
relationship between caregiver discrimination and adolescent depression. Employing linear mixed models, we
will examine the dynamic interplay of these variables over time. We will also investigate the influence of
multiple psychosocial and environmental factors to explore how they shape the relationship between caregiver
experiences and adolescent depression. By adopting a transdisciplinary approach and collaborating with
experts in latent class analysis, longitudinal methods, and racism scholarship, this research seeks to provide
novel insights into the determinants of adolescent mental health. Our ultimate goal is to develop a
comprehensive framework that integrates social and physical environments, caregiver discrimination, and
adolescent depression. The outcomes of this research will guide targeted interventions and policies to create
healthier and more supportive environments for vulnerable adolescents.
In summary, this study will contribute to advancing the field of public mental health by bridging existing gaps
in knowledge and practice. It will provide innovative solutions for addressing the mental health needs of
adolescents and help reduce disparities in depression rates, ultimately improving the well-being of the next
generation.

Public health relevance
PROJECT NARRATIVE There is considerable interest in understanding factors that impact adolescent experiences of depression. We propose to conduct secondary data analysis with latent class and mixed modeling methods to holistically answer the question “How do caregiver experiences of discrimination, psychosocial factors, and environmental influences interact to influence adolescent depression over time?”. Findings from this study will improve our understanding of these complex dynamics, contribute to a more comprehensive understanding of the factors that impact adolescent depression, and could inform interventions and policies to support the well-being of adolescents in diverse contexts.